Improving Mental Health for Veterans with Dementia: Provider Training in Caregiver Engagement

Background: This career development proposal is designed to prepare Mary Wyman, PhD for a VA career
conducting health services research focused on improving mental health care delivery and access for aging
Veterans. Dr. Wyman will accomplish this goal by completing training activities, obtaining expert mentorship, and
completing a series of research studies on family caregiver engagement in mental health services for Veterans
with dementia. Comorbid mental health conditions (e.g., depression and anxiety) are common in dementia and
are associated with worse outcomes if left untreated. To improve care quality and access, it is critical to effectively
involve family caregivers in mental health services; however, providers lack the confidence and skills to do so.
The primary objectives in this CDA application are 1) to use a qualitative research approach to identify facilitators
and barriers to caregiver engagement; 2) develop and test a provider training curriculum to increase skills in
engaging caregivers; and 3) use an existing dataset combining longitudinal survey data and VA health care
records to explore how caregiving associates to use of mental health services among Veterans with dementia.
Significance/Impact: This work has the potential to have significant and meaningful impact on the delivery of
mental health care to aging Veterans. Our methodology will support rapid dissemination and implementation of
the final, effectiveness-tested intervention, and our findings can inform development of future interventions to
address modifiable factors associated with mental health care access and outcomes. This work aligns strongly
with VHA and HSR&D priorities, including increased access to care, mental health and suicide prevention,
caregiver support, and employee engagement.
Innovation: While there are several effective interventions aimed at caregivers, we propose an innovative
approach to increasing caregiver involvement in mental health care by training providers in knowledge and skills
for effective caregiver engagement. As such, our proposal offers new directions for improving mental health care
quality and access for aging Veterans. The resultant systems intervention may be applicable across VHA care
settings and could positively impact employee engagement through increased provider self-efficacy.
Specific Aims: Objectives will be achieved through three specific aims: 1) Identify patient-, provider-, and
system-level factors that support or impede caregiver engagement in mental health care for aging Veterans with
dementia; 2) Develop and pilot-test a provider training curriculum and implementation strategy to improve mental
health provider engagement of caregivers of Veterans with dementia; 3) Examine associations of intensity of
informal caregiving received and cognitive status with MH care utilization by aging Veterans.
Methodology: Aim 1 involves semi-structured interviews with Veterans with dementia, their caregivers, and
mental health providers and leadership. Aim 2 will use established methodology to develop, refine, and pilot-test
a provider training and implementation strategy for the mental health setting. In Aim 3, data from the VA-Health
& Retirement Study Aging Veterans Cohort will be analyzed to explore associations between caregiving,
cognitive status, and mental health care utilization.
Next Steps/Implementation: During the CDA period, a proposal will be submitted to fund an adequately
powered “real-world” efficacy trial of the training curriculum. Dr. Wyman will work with local and national VHA
dissemination partners to disseminate study results and the final, effectiveness-tested intervention. Embedded
in the Madison VA GRECC and the rich environment of the University of Wisconsin, which offers extensive
infrastructure to support early stage investigators, Dr. Wyman is in an ideal environment to complete the
proposed research and training, allowing her to successfully launch as an independent investigator in VHA.

Public health relevance
Cognitive deficits such as dementia are common among aging Veterans, and mental health concerns such as depression and anxiety often co-occur with dementia. Although effective mental health interventions exist, these conditions are undertreated among Veterans with dementia. Family caregivers play an essential role in supporting the health care needs of Veteran with dementia, but are often not adequately involved by the health care team. Effective engagement of caregivers by providers in the mental health care setting may improve care quality and access. This CDA proposal addresses VA’s urgent need to 1) understand how caregivers can be more effectively engaged in mental health care for aging Veterans; 2) test a provider intervention designed to improve mental health provider skills in effective collaboration with family caregivers of Veterans with dementia; and 3) characterize how caregiving and cognitive deficits are related to use of mental health services by aging Veterans.